RECONFIG - REcovery of CONsciousness Following Intracerebral hemorrhaGe

Unconsciousness is common after acute brain injury such as a brain hemorrhage, and recovery is poorly
understood. This lack of knowledge is a key impediment to the development of novel strategies to improve
outcomes, and is one of the main reasons that prognostication of recovery of consciousness and functional
outcomes is inaccurate. One fifth of clinically unconscious patients with acute brain injury are able to follow
commands using a simple, bedside EEG motor imagery test that directly measures brain activity associated
with the attempt to move. This state is called cognitive motor dissociation (CMD). Pilot data indicates that CMD
patients are more likely to clinically recover consciousness and have better long-term functional outcomes than
non-CMD patients. To integrate these findings into clinical practice we need to better understand the trajectory
of CMD. This will only be possible in a tightly-controlled study with a homogenous patient cohort that is well
characterized early after the injury and captures long-term outcomes. The over-arching hypothesis of this
application is that once confounders are accounted for, recovery of consciousness follows a predictable course
with CMD (diagnosed by an EEG motor imagery paradigm) being a transitory state from unconsciousness to
emergence of consciousness. Characterizing the trajectory of recovery will be the overall goal of this
application. We propose a two-center, observational cohort study of patients presenting with primary
intracerebral hemorrhage (ICH) in the frontal lobe, thalamus, or striatocapsular region who do not have major
bleeding in other regions (e.g., midbrain). We will divide ICH patients into two cohorts- conscious and
unconscious. In the unconscious cohort, we will determine the time from injury to clinical command following
with time to CMD as a time-varying covariate (Aim 1), and determine if CMD predicts long-term functional
outcome (Aim 2). In the conscious cohort we will determine if patients with sensory aphasia are able to show
command following when tested with the EEG motor imagery paradigm (Aim 3). To answer questions posed in
Aims 1 and 2, we will study ICH patients that are unresponsive to commands. We will determine if location and
volume of ICH and electrophysiological features on resting EEG are associated with time to CMD. We will
determine if CMD independently predicts 6-month modified Rankin Scale after controlling for known predictors.
To address Aim 3 we will study conscious ICH patients with and without sensory aphasia using the EEG motor
imagery paradigm. This project will determine if CMD is a state that patients predictably transition through as
they recover from an unconscious to a conscious state and quantify the false negative rate for command
following in aphasic patients. These insights will fill an important gap in the understanding of impairment and
recovery of consciousness of this common form of stroke that will likely be generalizable to other brain injuries.

Public health relevance
Bleeding in the brain frequently results in unconsciousness and while recovery is common, it is difficult to predict when and if this occurs. A patient may recover weeks or even months after a bleed. We aim to develop measures of brain function that would more accurately predict recovery and associated societal reintegration of patients with brain bleeds.